Integrating Automated Mesh Development into the NA-MIC Toolkit

[unreadable] DESCRIPTION (provided by applicant): Musculoskeletal finite element (FE) analysis is an invaluable tool in orthopedic-related research. While it has provided significant biomechanical insight, the demands associated with modeling the geometrically complex structures of the human body often limit its utility. The often-prohibitive amount of model development time is further compounded by the time required to process medical image datasets to identify the distinct anatomical structures of interest. Yet this process is a necessary preprocessing step for model development. As a result, most of the analyses reported in the literature refer to 'average' bone geometry. The broad objective of our research plan is to integrate and expand methods to automate the development of specimen- / patient-specific finite element (FE) models into the NA-MIC toolkit. In pursuit of this objective we propose to merge unique technologies to automate image dataset segmentation; material property extraction and assignment; and direct FE model development (automated meshing). While direct physical scans of the bones of interest will be used to validate the automated image segmentation routines, experimental cadaveric contact stress measurements will provide a standard against which to validate the FE contact formulations. Furthermore, the FE models generated by our software package will be compared to models of the same bone(s) created via a commercial pre-processing package. While the bones/joints of the upper extremity represent the primary structures of interest proposed in this application, the tools will be applicable to many orthopedic applications. In addition to expanding the NA-MIC toolkit beyond the brain, the proposed project will expand the image segmentation routines and finite element meshing routines currently available. This proposal will ultimately yield specimen-specific FE models of the various joints of the upper extremity. Such models will position us to provide information about the load transfer, characteristics of the normal joints and in the future to demonstrate, for example, the effects of ligamentous instabilities, posttraumatic misalignments, fractures, and various surgical procedures. [unreadable] [unreadable] [unreadable]